Intra-tick and intra-host infection dynamics of a tick-borne bunyavirus

PROJECT SUMMARY & ABSTRACT
Severe fever with thrombocytopenia syndrome (SFTS) is an emerging tick-borne disease caused by the
bunyavirus, SFTS virus (SFTSV). SFTSV is transmitted by the Haemaphysalis longicornis tick, which is native
to East Asia but recently established invasive populations in the United States and continues to expand in
geographic range. The rising incidence of SFTS cases in Asia, lack of specific treatment strategies, high case
fatality rates, and global range expansion of the tick vector make SFTS a public health concern. As a tick-borne
virus, SFTSV is unique from single-host viruses because it must replicate and survive in both vertebrate and
invertebrate hosts. Currently, there is a critical need to elucidate the intra-tick and intra-host infection dynamics
that enable bunyaviruses to infect, disseminate, and persist within the distinct environments of the tick and
vertebrate host. Acquiring this fundamental knowledge is paramount to developing novel strategies that prevent
SFTSV transmission. This research proposal is in direct response to NIH RFA-AI-21-046, “Promoting
Bunyavirales Basic Science Research.” The overall objective is to define the dynamics of SFTSV infection,
dissemination, and cell tropism within the tick vector, as well as the tick-to-host transmission timeline and initial
SFTSV–host interactions in the skin. The central hypothesis is that biotic factors associated with H. longicornis’
life cycle facilitate intra-tick SFTSV dissemination to the salivary glands after molting, which in turn enables the
tick to rapidly transmit SFTSV to the next vertebrate host on which it feeds while creating an immunologically
privileged microenvironment at the skin site of tick feeding. The central hypothesis will be tested by pursuing two
specific aims: 1) Characterize the dynamics of SFTSV infection, dissemination, and transstadial survival within
H. longicornis ticks; and, 2) Define the minimum tick-to-host transmission time of SFTSV and the early host
cutaneous immune response to SFTSV-infected tick feeding. Completion of these aims will define the infection
kinetics and cell tropism of SFTSV within the tick vector across multiple life stages and within the skin of the
vertebrate host. The proposed studies will be the first to collectively examine the intra-tick and intra-host infection
dynamics of a tick-borne bunyavirus. Elucidating the fundamental H. longicornis–SFTSV–vertebrate host
interactions will enable future work towards the development of rational interventions that disrupt virus survival
within, and transmission between, the tick and vertebrate host.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will provide us with fundamental knowledge of the intra-tick and intra-host infection biology of the tick-borne bunyavirus, severe fever with thrombocytopenia syndrome virus (SFTSV). Due to its high case fatality rate, ability to cause hemorrhagic disease, and lack of specific treatment strategies, SFTSV is considered a priority infectious disease by the World Health Organization. Elucidating the basic infection biology of SFTSV within the Haemaphysalis longicornis tick and within the skin of the vertebrate host will lay the foundation towards developing novel interventions that disrupt SFTSV transmission and survival.